Regulation of xenobiotic receptors PXR and CAR, and CYP3A: implications in drug disposition

Manipulation of drug disposition offers an avenue toward enhancing drug efficacy and reducing adverse drug
effects (including drug toxicity and drug resistance, the leading causes of drug treatment failure). We study the
regulation of human pregnane X receptor (hPXR), constitutive androstane receptor (hCAR), cytochromes P450
(CYP)3A4 and CYP3A5, along with their roles in drug disposition. hPXR and hCAR are nuclear receptors
modulated by many structurally diverse chemicals. They transcriptionally regulate transporters and drug-
metabolizing enzymes (including CYP3A4 and CYP3A5, which metabolize more than 50% of prescribed drugs)
to control xenobiotic disposition and endobiotic homeostasis, and are implicated in drug effects and in the
development of human diseases (e.g., diabetes and cancer). Several key gaps remain in our understanding of
the regulation of hPXR, hCAR, CYP3A4, and CYP3A5. First, hPXR and hCAR display ligand promiscuity and
structural flexibility, but how compounds affect receptor activities, and how the two receptors co-regulate drug
disposition, remain elusive. An innovative and systematic effort is needed to develop chemical tools to dissect
hPXR and hCAR regulation in detail. Second, how CYP3A4 and CYP3A5 are differentially regulated in a tissue-
and disease-context–dependent manner is unknown. Our two long-term goals are 1) to comprehensively
understand the regulation of hPXR, hCAR, CYP3A4, and CYP3A5 and its implications for drug disposition and
human diseases, and 2) to develop chemical tools to elucidate their regulation, prevent drug toxicity, and improve
drug bioavailability. We have advanced toward these goals by discovering novel mechanisms that regulate
hPXR, hCAR, and CYP3A5 (including transcriptional, post-transcriptional, and post-translational regulation, and
previously unknown protein–protein interactions), and by developing novel compounds that specifically target
them. We will meet 3 challenges during the next five years: (1) The mechanism by which binders of hPXR or
hCAR trigger varying cellular outcomes to differentially affect xenobiotic metabolism is still not well defined,
hindering our ability to accurately assess drug effects. We will develop compounds and assess their mechanisms
of action and in vivo efficacy. (2) The functional relation between hPXR and hCAR and the underlying mechanism
remain unclear, preventing an effective modulating approach. We will fully characterize the relation and develop
compounds to modulate it and xenobiotic metabolism. (3) How CYP3A4 and CYP3A5 are differentially regulated
is unclear. We will develop CYP3A5-specific inhibitors, identify the regulators of CYP3A5 expression, and
develop appropriate cell models and advanced technological approaches to investigate the novel roles of
CYP3A5. Together, our findings will provide a broader comprehension of the regulation of hPXR, hCAR,
CYP3A4, and CYP3A5; define the previously unclear functional relation between hPXR and hCAR and design
paradigm-shifting approaches to modulate it; reveal novel regulation and roles of CYP3A5; and generate novel
chemical compounds as leads for therapies to prevent drug toxicity and improve drug bioavailability.

Public health relevance
Project Narrative We propose to study the role of xenobiotic receptors and drug-metabolizing enzymes in drug-induced toxicological effects, the leading cause of treatment failure. We will develop and characterize novel compounds and determine their mechanisms and effects in preventing drug-induced toxicological effects and increasing intracellular drug accumulation. The results of our proposed studies will illustrate how drugs cause toxicological effects and will identify potential therapeutic approaches to prevent such toxicological effects and improve treatment efficacy.